Intervention Research to Improve Native American Health

This participatory, pragmatic efficacy-implementation trial evaluates the impact of Promoting Community
Conversations About Research to End Suicide (PC CARES) on adult participants and the adults and youth they
are ‘close to’, who we hypothesize will benefit from the intervention. For sustainability, the project also identifies
barriers and enablers to community implementation of PC CARES in rural Alaska Native (AN) communities.
Using a multilevel growth model, we examine the changes in suicide prevention knowledge, self-efficacy,
collaborations for a ‘community of practice’ (CoP) and prevention-oriented behaviors of adult PC CARES
participants (n=250) over time (7 timepoints), testing for moderating effects of dosage (e.g. #LCs attended),
community ‘readiness’; cross-sector participation on outcomes to inform future PC CARES implementation
(AIM#1). Over the same time periods in six randomly selected communities, our communitywide adult and youth
measures assess the community-level mechanisms of change (social diffusion), and for the first time, track youth
outcomes (AIM#2). We hypothesize that PC CARES will encourage adults to develop a collaborative
relationships within a CoP to implement upstream suicide prevention best practices (SPBPs) in support of youth
in their lives. Using community level social network measures, we document the number and type of interactions
reported by adults (n=450) over time, capturing social diffusion by comparing the knowledge, self-efficacy, CoP
and prevention-oriented behaviors of (1) PC CARES participants, (2) non-participants who are ‘close to’
participants and (3) others, unrelated to participants (comparison group). To assess youth impact (n=300, ages
12-19), we measure youth reported supportive adult interactions and connectedness (over 7 time points), and
pre-post perceived social support, family and community protective factors, comparing outcomes for youth who
are ‘close to’ participants versus 'unrelated' youth (comparison group). AIM#3 combines community-engaged
methodologies and evidence-based implementation science frameworks to examine the barriers and enablers
of PC CARES implementation in AN communities. The proposed study fulfills the priorities of the Intervention
Research to Improve Native American Health (PAR-17-496) because it: (1) tests the effectiveness of a promising
suicide prevention intervention developed with and for AN communities; (2) builds on cultural and community
knowledges as well as scientific best practices; (3) examines adult participant outcomes and diffusion at a
community level, (4) tracks the impact of adult prevention behaviors on youth-reported protective outcomes,
which promote mental health, safety and buffer suicide risk, and (5) by partnering with a successful educational
pathway for AN community mental health workers, our study of barriers and enablers of implementation will pave
the way for feasibly scaling PC CARES to other rural and remote AIAN communities who suffer disproportionately
from youth suicide. This project contributes to our long-term goal of translating suicide prevention research into
culturally-responsive community practice to reduce suicide risk and promote youth wellbeing in AN communities.

Public health relevance
Narrative Our proposal addresses American Indian/Alaska Native (AIAN) youth suicide, an urgent health inequity that is difficult to address in underserved rural and remote AIAN communities. We test a promising translational intervention that leverages strong social networks in rural AN communities to increase uptake of evidence-based and culturally responsive suicide prevention strategies, with a goal of reducing the risk of suicide and promoting safety and mental health of young people in AIAN communities. This kind of evidence-informed, community-led intervention has potential to scale to other AIAN and underserved communities to address the growing crisis of youth suicide.